Trends in C-Section and Induction Use among US Births and Consequences for US Birth Weight

Project Summary Average birth weights in the United States declined substantially during the 1990s and 2000s and have not recovered to the birth weight levels prior to the declines. This project documents state-level birth weight trends among U.S. infants born to non-Hispanic black, non-Hispanic white, and Latina women between 1990 and 2014. The project investigates the extent to which increased rates of cesarean section deliveries (C-sections) and labor inductions were responsible for recent changes in U.S. birth weights. Existing research has thus far reported no link between birth weight declines in the United States and the increased use of C-sections and inductions. Futher, existing evidence suggests that changes in U.S. birth weight distributions have occurred across all weeks of gestational age. The anomalous declines in U.S. birth weights are therefore suspected to reflect sources of reduced fetal growth that have been independent of gestational age. However, analytic approaches from extant research have overlooked how the composition of births at gestational ages have changed as a result of rising use of C-sections and inductions. Increased uses of C-sections and inductions have not been random. Rather, they have disproportionately occurred at select gestational ages, which have dramatically shifted when U.S. births take place and how. These labor interventions often affect pregnancies that likely would have resulted in births taking place at older gestational ages and at higher birth weights if the interventions did not occur. The consequences of these changes have altered both the distribution of U.S. births across gestational ages as well as the birth weight distributions of these births. This project will explore how these compositional changes may be responsible for declines in birth weight among infants born to U.S. non-Hispanic black, non-Hispanic white, and Latina mothers in all states between 1990 and 2014. The project will analyze gestational age distributions and birth weight distributions in official National Vital Statistics Systems Natality files for years 1990, 1996, 2002, 2008, and 2014. Traditional demographic techniques and survival models will be used to estimate changes in the joint probabilities of births occurring at specific gestational ages via specific birthing methods (i.e., C-section, induction, or vaginal without intervention). Simulation techniques will be used to illustrate how birthweight distributions among non-Hispanic black, non- Hispanic white, and Latina women in all U.S. States would have changed if rates of C-section use and rates of induced labor had remained constant over the years. The analytic approach of the project is novel and goes well-beyond existing analyses by paying special attention to compositional changes in U.S. births in terms of birth method, birth timing, and birth weight. Findings from the project will contribute significantly to research in demography and public health, and potentially inform obstetric practices and policies.

Public health relevance
PROJECT NARRATIVE The purpose of this project is to examine how declines in average U.S. birth weight between 1990 and 2014 were associated with rising rates of cesarean deliveries and induced births in the United States. This project will use survival modeling techniques and simulations to account for compositional changes in U.S. birth timing, birth method, and birth weight. The project will also examine State and race/ethnic differences in the effects of cesarean deliveries and labor inductions on U.S. birth weight distributions.